Project 2: Smokers

PROJECT 2:

Public health relevance
PROJECT NARRATIVE Cigarette smoking is a leading cause of morbidity and mortality from lung cancer among adults in the US; smoking cessation is the best preventive strategy for reducing lung cancer risk and addressing racial disparities in outcomes. Despite this, many smokers are unwilling or unable to make a quit attempt, and among those who try to quit smoking, utilization of evidence-based treatment is poor, especially in racial minorities. Stress relief, and the avoidance of adverse psychological and physiological reactions, are among the primary reasons for smoking initiation, maintenance, and relapse in all populations; there is an established relationship between perceived stress and smoking behaviors from observational studies. However, stress responses have both psychological and physiological consequences that are important to smoking behaviors and cessation outcomes. Despite the significance of the HPA-axis pathway for both stress responses and nicotine addiction, racial differences in physiological stress responses have not been examined between African American/Black (AA/Black) and white smokers. Under the leadership of an expert transdisciplinary investigative team that is supported by critical cores and shared resources for community engagement, biospecimen collection, storage, and processing, and biostatistics and bioinformatics in the Translational Research Center in Lung Cancer Disparities (TRACER), Project 2 will be the first to examine racial differences in HPA-axis functioning between AA/Black and white male smokers to achieve the following specific aims: Aim 1: Examine racial differences in acute physiological stress responses between AA/Black and white male smokers using a laboratory model. The association between acute physiological stress response and tobacco-related behaviors will also be evaluated. Hypotheses: AA/Black smokers will be more likely than white smokers to have a blunted cortisol response to an acute laboratory stressor. AA/Black smokers will also have significantly greater cigarette craving and be more likely to smoke following exposure to an acute physiological stressor compared to white smokers following an acute laboratory stressor. Aim 2: Evaluate racial differences in daily cortisol patterns between AA/Black and white male smokers. Hypotheses: AA/Black smokers will be more likely than white smokers to have blunted daily diurnal cortisol slopes. Compared to white smokers, AA/Black smokers will have lower absolute cortisol values during the waking day. Aim 3: Identify factors that are important to acute and daily stress responses among AA/Black and white male smokers by examining acute and daily cortisol patterns based on exposure to chronic stressors. Hypotheses: Acute and daily cortisol responses will be associated with chronic stressors such that men who have greater exposure to SES, structural, and psychosocial stressors will have blunted acute and daily cortisol patterns. The relationship between acute and daily cortisol patterns, nicotine metabolism, and nicotine dependence will also be explored among AA/Black and white male smokers as part of this aim.